Oocyte polarity and mRNA localization in Zebrafish

DESCRIPTION (provided by applicant): Asymmetry in oocytes is a well-documented and conserved feature among animals including vertebrates and humans. In vertebrates, the earliest indicator of cell polarity is an asymmetric aggregate, known as the Balbiani body, that includes organelles, proteins, and, in some animals, mRNAs encoding germline determinants. In non-mammalian vertebrates, this early asymmetry is known to indicate the animal-vegetal axis, but the relationship between the Balbiani body and the animal-vegetal axis in mammals is not understood. Although the animal- vegetal axis is the first axis to form in vertebrates, and is crucial for normal development of the embryonic axes that form later in development, its specification is poorly understood. In a maternal-effect genetic screen we isolated 2 alleles of bucky ball (buc), mutants that lacks oocyte asymmetry and fails to establish the axes in embryos. The Buc protein does not contain any characterized or known functional domains based on sequence comparison, but other vertebrates including humans have bucky ball genes. The buc gene, and our mutant alleles provide the first genetic access and a unique entry point to the developmental pathway regulating oocyte polarity. Here three aims are proposed to study how cell polarity is established and maintained in the vertebrate ovary. 1) We will test the hypothesis that buc specifies the oocyte axis upstream or at the level of Balbiani body assembly. 2) We have identified Buc interacting proteins. We will study these interacting proteins, and conduct rescue based structure function analysis to identify Buc functional domains to understand the mechanism by which Buc regulates animal-vegetal polarity. 3) We will determine which factors mediate asymmetric buc mRNA localization and contribute to oocyte polarity. Understanding how the Balbiani body, a conserved oocyte asymmetric structure, forms in vertebrates will break new ground in the field of axis formation. Studies of the genetic and molecular control of axis formation in zebrafish will clarify the mechanisms establishing these earliest oocyte asymmetries, which are conserved. In humans, mutations disrupting genes required to specify oocyte polarity or the first embryonic axis are expected to result in failed implantation or miscarriage due to severe developmental abnormalities. These most severe birth defects often are not detected in humans. In model systems such as zebrafish where fertilization and development of the embryo occur externally every egg that is produced can be examined for developmental abnormalities. Thus, this vertebrate genetic system allows access to maternally regulated developmental processes. An improved understanding of the essential maternal genes regulating early embryonic development in zebrafish will provide insight into the basis of birth defects and miscarriage, and facilitate comparison with human proteins. Studies of the Buc pathway are expected to be particularly relevant to abnormalities arising in very early pregnancy since buc mutant females produce eggs that are fertilized, but fail to specify the embryonic germ layers or axes. Completing these studies will provide insight into how Bucky ball regulates Balbiani body formation and oocyte asymmetry. These studies represent a first step toward deciphering the genes and mechanisms, mediating an evolutionarily conserved feature of primary oocyte development that is predicted to play fundamental roles in fertility, and in some vertebrates, establishment of the embryonic axes.

Public health relevance
PUBLIC HEALTH RELEVANCE: Prior to zygotic genome activation, vertebrate development depends on maternally supplied factors. However, the identity of the essential components and the molecular mechanisms underlying many maternally driven processes are not known. Mutations disrupting strict maternal-effect genes are viable. The mutant females are overtly normal, due to maternal function supplied by their mother. However, all of their progeny display the mutant phenotype regardless of their genotype. Although maternal products are essential for vertebrate development, only a small fraction of the vast numbers of vertebrate genes with maternal expression have been experimentally evaluated through genetic or by interference technologies. In each of these cases, insufficient maternal contribution results in early embryonic arrest, or profound developmental abnormalities. Similar genetic defects in humans would be expected to result in failed implantation or miscarriage before pregnancy is detected. Ten to twenty percent of known pregnancies result in miscarriage; however, when combined with undetected pregnancies, the actual percentage of pregnancies ending in miscarriage is estimated to be as high as 40-50% of all pregnancies, according to The March of Dimes, The American College of Obstetricians and Gynecologists, The Mayo clinic, and the National Institutes on Child Health and Development. Our research goal is to elucidate the genetic pathways and cell biological events that establish the first embryonic axis. We will use a combination of genetic, molecular, and cell biological approaches in the zebrafish model system. In humans, loss of function mutations in genes whose products are required to specify the first embryonic axis are expected to result in miscarriage due to severe developmental abnormalities. Studies of the genetic and molecular control of axis formation in zebrafish will clarify the genetic basis of animal-vegetal axis formation, potentially illuminating the genetic basis of human birth defects, and early miscarriages of unknown etiology. Prior to zygotic genome activation, vertebrate development depends on maternally supplied factors. However, the identity of the essential components and the molecular mechanisms underlying many maternally driven processes are not known. Mutations disrupting strict maternal-effect genes are viable. The mutant females are overtly normal, due to maternal function supplied by their mother. However, all of their progeny display the mutant phenotype regardless of their genotype. Although maternal products are essential for vertebrate development, only a small fraction of the vast numbers of vertebrate genes with maternal expression have been experimentally evaluated through genetic or by interference technologies. In each of these cases, insufficient maternal contribution results in early embryonic arrest, or profound developmental abnormalities. Similar genetic defects in humans would be expected to result in failed implantation or miscarriage before pregnancy is detected. Ten to twenty percent of known pregnancies result in miscarriage; however, when combined with undetected pregnancies, the actual percentage of pregnancies ending in miscarriage is estimated to be as high as 40-50% of all pregnancies, according to The March of Dimes, The American College of Obstetricians and Gynecologists, The Mayo clinic, and the National Institutes on Child Health and Development. Our research goal is to elucidate the genetic pathways and cell biological events that establish the first embryonic axis. We will use a combination of genetic, molecular, and cell biological approaches in the zebrafish model system. In humans, loss of function mutations in genes whose products are required to specify the first embryonic axis are expected to result in miscarriage due to severe developmental abnormalities. Studies of the genetic and molecular control of axis formation in zebrafish will clarify the genetic basis of animal-vegetal axis formation, potentially illuminating the genetic basis of human birth defects, and early miscarriages of unknown etiology. __SpecificAimsTextDelimiter__ 5.5.2. SPECIFIC AIMS I propose to study how cell polarity is established and maintained in the vertebrate oocyte and egg. Asymmetry in oocytes is a well-documented and conserved feature among animals. In vertebrates, the earliest indicator of cell polarity is the Balbiani body, an asymmetrically localized aggregate comprised of organelles, proteins, and, in some animals, mRNAs encoding germline determinants and patterning molecules. Where known in vertebrates, the Balbiani body is the earliest indicator of the animal-vegetal axis. The vertebrate animal-vegetal axis forms first, and is a prerequisite for normal development of the later developing embryonic axes, however its specification is poorly understood. In mammals including humans, loss of function mutations in genes required to specify the animal-vegetal axis are expected to result in miscarriage due to severe developmental abnormalities or failed implantation. Consequently, these most severe birth defects often are not detected. This limitation in accounting for every pregnancy is inherent in mammalian systems; therefore, we use the zebrafish model system where fertilization and development of the embryo occur externally. Thus every egg produced can be examined for developmental defects. In a maternal-effect genetic screen we isolated 2 mutant alleles of bucky ball (buc). Lack of maternal Buc causes failure to establish oocyte asymmetry and the embryonic axes through an unknown pathway and mechanism. The Buc protein lacks characterized or known functional domains, but other vertebrates including humans have buc genes. To determine the mechanism via which Buc regulates oocyte asymmetry we have identified candidate components of the Buc pathway through yeast genetic and affinity purification approaches. Here we propose to study three of these proteins and to test our hypothesis that Buc regulates oocyte polarity upstream of Balbiani body formation in part by recruiting proteins that mediate assembly of a dynamic complex composed of RNAs and proteins. Our proposed studies combine biochemical and oocyte culture approaches, and exploit the unique genetic access afforded by our buc mutant alleles to improve our understanding of Buc function and the mechanisms mediating oocyte polarity and animal-vegetal axis formation in a vertebrate model system. Aim 1. To test the hypothesis that buc specifies the oocyte axis upstream or at the level of Balbiani body assembly. (1.1) As an indicator of the temporal action of Buc activity, we will determine the spatial and temporal localization of endogenous Buc protein prior to Balbiani body formation using Buc antibodies. (1.2) To understand whether polarity is established before the Balbiani body forms, we must first determine the basic organization of the germline cyst. Specifically we will examine elements of the Actin and microtubule cytoskeleton to determine whether the cytoskeleton is necessary for polarized localization of buc gene products or Balbiani body formation. We will examine the localization of intracellular trafficking components in wild-type and bucky ball mutants to determine whether defective trafficking contributes to the buc mutant phenotype. Aim 2. To understand the mechanism through which Buc regulates animal-vegetal polarity. To appreciate how Buc regulates animal-vegetal polarity we need to know Buc's binding partners and functional domains. We will study two proteins, Dazap2 and Hermes/Rbpms, identified as Buc interacting proteins through the yeast-two-hybrid approach. We will test the hypothesis that Buc regulates animal-vegetal polarity in part by recruiting these RNA binding and putative protein scaffolding proteins. (2.1) We will map the binding domains for Hermes/Rbpms and Dazap2, using yeast genetics and co-immunoprecipitation approaches. (2.2) Previously I showed that localization of Rbpms requires Buc function. Here we will investigate Dazap2 spatial and temporal distribution during oogenesis, and whether Dazap2 localization or abundance depends on Buc function. (2.3) We will take an unbiased approach to identify functional regions of Buc through oocyte culture rescue assays. Using the same assays we will test whether the Buc:Dazap2/Rbpms binding domains are necessary for rescue. Aim 3. To determine which factors mediate asymmetric buc mRNA localization and contribute to oocyte polarity. (3.1) To test the hypothesis that elements within the bucky ball 3'UTR function as cis-acting localization sequences to target zebrafish buc mRNA, we will directly test whether candidate trans-acting localization factors, Dazl and Dazl associated protein 1 (Dazap1), bind to the buc3'UTR. (3.2) In an unbiased approach, we identified Rbp9 by ms/ms analysis of proteins affinity purified with Biotinylated-buc3'UTR. To determine how Rbp9 interacts with buc we will map the Rbp9 cis-binding sites, then we will mutate those sites to investigate whether they are necessary for Rbp9 binding and for localization of buc mRNA along the oocyte animal-vegetal axis or its stability. Completing these studies will provide insight into Buc regulated Balbiani body formation and oocyte asymmetry. These studies are among the first to apply maternal-effect genetics in a vertebrate to decipher the genes and mechanisms that establish conserved oocyte asymmetries and the animal-vegetal axis.